PLA2R1 Loss-of-Function: A Monogenic Cause of Sarcoidosis in African-Americans in the ACCESS Cohort

PROJECT SUMMARY/ABSTRACT
Sarcoidosis is a chronic multi-organ granulomatous disease of unknown etiology, typically characterized
by lung involvement, which disproportionately affects African-American women. Sarcoidosis is thought to be
caused by environmental factors in the setting of a genetically susceptible host. Although sarcoidosis has a
significant genetic basis, the genetic architecture of sarcoidosis risk is poorly defined. In preliminary studies,
the PI's team has performed a phenome-wide association study (PheWAS) using the Vanderbilt University's
genetic biobank (BioVU) to investigate the phenotypic consequences of an African ancestry-specific loss-of-
function frameshift variant in the PLA2R1 gene. PLA2R1 encodes the phospholipase A2 receptor (PLA2R), a
transmembrane protein from the mannose receptor family, whose biological function is not clearly understood.
We have unexpectedly discovered that African-Americans homozygous for the PLA2R1 frameshift variant have
about 5-fold higher risk of sarcoidosis and 10-fold higher risk of tuberculosis. The objective of this research is
to corroborate and expand upon these preliminary findings by analyzing biospecimens from “A Case Controlled
Etiologic Study of Sarcoidosis (ACCESS)” as an independent validation cohort. Our central hypothesis is that
PLA2R1 deficiency increases the risk of sarcoidosis among African-Americans in the ACCESS study, in part
by increasing susceptibility to latent infection with Mycobacterium tuberculosis. Studies proposed in Aim 1A
seek to validate genetic PLA2R1 deficiency as a monogenic cause of sarcoidosis among African-Americans in
the ACCESS study. Aim 1B will establish whether genetic PLA2R1 deficiency increases sarcoidosis risk
specifically among African-Americans with latent tuberculosis infection. Aim 2 will determine whether
sarcoidosis may be triggered by an acquired PLA2R loss-of-function triggered by the development of inhibitory
anti-PLA2R auto-antibodies. The rationale for these studies is that a detailed understanding of the phenotypic
consequences of the complete PLA2R1 deficiency is a powerful tool to unveil the actual biological roles of
human PLA2R using human genetics. This collaborative research project is highly responsive to RFA-HL-23-
018 because it will leverage unique resources from the NHLBI BioLINCC biorepository (DNA and plasma
specimens from the ACCESS study) to investigate a novel genetic cause of sarcoidosis in African-Americans.
The proposed research is innovative because it would represent the first example of a monogenic cause of
sarcoidosis, while providing insights into novel unexpected biological functions of human PLA2R1. This
research is significant because genetic PLA2R deficiency could explain as many as 4% of all cases of
sarcoidosis in African-Americans, which is highly relevant to understanding health disparities in this disease.

Public health relevance
PROJECT NARRATIVE: Sarcoidosis is a multi-organ granulomatous disease of unknown etiology, most commonly affecting the lungs, which may progress to pulmonary fibrosis. This project will use biospecimens from the NHLBI biorepository (BioLINCC) to test the hypothesis that PLA2R loss-of-function is a monogenic cause of sarcoidosis among African-Americans from the “ACCESS” (A Case Controlled Etiologic Study of Sarcoidosis) cohort.